Surgical site infections and the role of anesthesia and bacterial ion transporters

Project Summary/ Abstract
The proposed research titled “Surgical site infections and the role of anesthesia and bacterial ion transporters”
is to study the impact of daily used anesthetic drugs on surgical site infections (SSIs) (exposure duration and
type of anesthetics) and the effectiveness of antibiotics in vivo and examine its underlying mechanism in vitro
under the hypothesis that volatile anesthetics (VAs), not intravenous anesthetic (IA) increase bacteria burden
in surgical wound by increasing biofilm formation via their direct interaction with bacterial ion transporters, and
also by attenuating host immune cells. SSIs are the most common surgical infections in the perioperative
setting, occupying 20% of in-hospital infections, and associated with significant morbidities, mortalities and
healthcare expenses. Up to 80% of SSIs are due to bacteria in biofilm form, not in planktonic form. We
previously reported in gram-negative bacteria Escherichia coli that 1) commonly used VAs isoflurane and
sevoflurane, not IA propofol increased biofilm formation, and 2) a group of bacterial ion transporters were
involved in biofilm formation, and 3) VAs enhanced the biofilm formation via affecting ion transporters. In this
proposal we plan to use gram-positive bacteria Staphylococcus aureus and Enterococcus faecalis strains,
common strains for SSIs. In Aim 1, we will determine the effect of common anesthetics on biofilm formation in
vitro under hypoxia to mimic oxygen level at wounds. The role of ion transporters in biofilm formation and their
direct interaction with VAs will be examined. In Aim 2, we will determine the effect of common anesthetics on
host defense, including phagocytosis of planktonic or biofilm bacteria cells in vitro under hypoxia and direct
binding of VA to gram-positive receptor toll-like receptor 2. In Aim 3, we will determine the impact of
anesthetics on biofilm-associated SSIs and the effectiveness of antibiotics in vivo. We will study the effect of
anesthetics on bacterial biofilm formation and innate immune cell functions in this model. Upon the completion
of the study, we expect to learn whether or not the type of anesthetics and the duration of their exposure affect
bacterial loads, biofilm formation and the effectiveness of antibiotics. All the anesthetics tested are in clinical
use and we expect that our study is highly clinically-relevant and readily translatable. Following the successful
completion of this study, we expect to have the foundation to examine the impact of anesthetic regimens on
SSIs in patients undergoing procedures with high risk of infection. The knowledge of anesthetic direct binding
to bacterial ion transporters for biofilm formation and to host defense receptor toll-like receptor 2, if learned in
this proposal, will not only increase our understanding of how volatile anesthetics work but also can lead us to
think of developing screening assays to rule out these interactions and develop anesthetics devoid of adverse
effects.

Public health relevance
Project Narrative: Volatile anesthetics have been given to patients for more than 150 years to provide general anesthesia in surgical procedures. Our previous data suggest that these anesthetics also affect the function of bacteria Escherichia coli and host immune cells, and can worsen the course of infection. This proposal is 1) to study the effect of anesthetics on surgical site infections and antibiotic susceptibility using a preclinical surgical site infection model infected with common pathogens Staphylococcus aureus and Enterococcus faecalis to test the hypothesis that volatile anesthetics worsen bacterial burden in surgical wounds by increasing biofilm bacteria, a bacterial form resistant to our host defense and antibiotic treatment, and attenuating the function of host immune defense, and 2) to examine the effect of anesthetics on bacteria and phagocytes under hypoxia to test the hypothesis that volatile anesthetics facilitate bacteria to become biofilm and also directly attenuate our host defense.